Health Professionals Education Partnership Initiative Ethiopia

Project Summary
The College of Health Science (CHS), Addis Ababa University (AAU) with partner institutions
(Dilla and Wolaita locally; and Alabama and Emory internationally) is submitting this application
entitled, “Health Professional Education Partnership Initiative” (HEPI) with the main objectives
of: Curriculum development for community-based multi-disciplinary team training program;
development and implementation of customizable research training modules in implementation
science and qualitative researchacross the three collaborating institutions; implementation of an
IT-supported, skills-based and simulation training modules with focus on chronic care, HIV, TB,
malaria and other emerging health problems; and strengthening of research related
infrastructure within the partnering institutions.
The proposed multi-disciplinary team training will encourage cross-breeding across various
disciplinary paradigms as well as simulate the situation where graduates will be working as a
team of health workers in actual field situation. It will also maximize human resources
utilization through joint planning in teaching common courses and in conducting research; and
create opportunities for collaborative research as well as for addressing the health needs of
the community in an integrated manner as a health team.
Developing customizable research modules for short term training in implementation science
and qualitative research methodology will be instrumental in improving treatment of under-
served populations and communities with limited access to health care. Particularity, an IT-
supported, skills-based & simulation training modules for training multi-disciplinary clinical
practice teams in chronic care, HIV, TB, malaria and other emerging health problems will be
important in developing the expertise for extending these training models into rural clinical and
training institutions. Furthermore, the proposed application intends to establish and strengthen
research related infrastructure that include research policies and guidelines, institutional
ethical review boards, as well as administrative and fiscal accountability processes.
The approaches for the proposed application include:
- Developing competency-based curricula for the pre-service trainings in medicine,
nursing, and pharmacy within the concept of multidisciplinary care delivery and shared
responsibility;
- Task-shifting within a multidisciplinary team framework that is planned to address the
long-term care needs of PLHIV across the different levels of the health system in the
catchment areas of the partnering institutions and through an outreach arrangement;
- Short-term training of students and junior faculty in implementation science and
qualitative research, grant writing, biostatistics, data management, and ethics; and
- Mentorship arrangements by senior faculty at AAU and the international partner
institutions for junior faculty within the local institutions in the partnership.
1

Public health relevance
Project Narrative Leveraging the experiences and successes from MEPI, NEPI and MEPI D43 programs that have been implemented within the AAU-CHS, the HEPI program envisages to build capacity at the consortium of local universities in the application in areas of multidisciplinary team training, research training and mentorship in implementation science and qualitative methodology. It will also build institutions for administering and supporting research activities within the universities. The proposed program will eventually be instrumental in facilitating team-based service delivery as well as contribute to the improvement of retention in rural areas of the full range of the health workforce required to address the prevailing double burden of communicable diseases and those of emerging non-communicable diseases. 1